Core C: Imaging Core

Abstract
The Imaging Core (Core C) will provide services related to sample processing, image acquisition and image
analysis for all PPG investigators. Due to the unconventional size and intricate polymeric organization of
mucins, studying complex biological systems like mucus require innovative, workable, and reliable
experimental approaches for proper investigations. Core C offers expertise in mucus-rich sample
handling/processing/staining and technical proficiency for image acquisition using a broad range of
microscopy techniques. Imaging techniques available through Core C include RNA-in situ hybridization,
immunohistochemistry, mucin agarose Western blotting, scanning and transmission electron microscopy, and
atomic force microscopy. The combination of all of these imaging techniques will provide alternative ways to
visualization key components of the mucociliary apparatus and gain insights into the molecular interactions
that govern the viscoelastic properties of mucus. In addition to providing high-quality micrographs, Core C
assists investigators with state-of-the-art image analysis using various software, (e.g., ImageJ, VisioPharm,
Odyssey) to ensure accurate quantitative analyses of digital images. Indubitably, the proper functioning of
Core C relies on partnerships established for years between the Ehre lab and existing microscopy facilities
(MSL and HIC) on UNC campus. The use of these recharge centers and their existing equipment has been
carefully allocated in the budget section. Core C is designed to provide protocols, reagents, as well as
expertise, guidance and technical assistance for sample processing, image acquisition and digital image
analysis for projects 1, 2, 3, and 4.